ABCD-USA Consortium: Coordinating Center

PROJECT SUMMARY/ABSTRACT
Adverse cardiometabolic profiles and health behaviors often begin to emerge in adolescence. The following
NHLBI Supplement Application outlines the proposal by the Adolescent Brain Cognitive Development (ABCD)
Study to augment the current data being collected on this cohort with information about the cardiometabolic and
hematologic health of youth during this time period. This additional data will include heart rate and blood
pressure, total cholesterol, HDL, HbA1C, CBC, ferritin, iron, and child nutrition. These data will provide key
information regarding the physiologic health of youth participating in ABCD and can be correlated with other data
on cognitive functioning and brain development. Furthermore, examining the relationship between these
physiologic outcomes and social and environmental exposures as well as lifestyle behaviors may help to
estimate their impact on adolescent health and identify targets for intervention. ABCD’s large sample size
(N=11,880) and diverse population will also enable researchers to develop a more nuanced understanding of
these relationships as they pertain to different sociodemographic populations. The data elements to be collected
in this supplement will be overseen by the ABCD Physical Health Assessment Workgroup with input from NHLBI.
The project will also add ABCD investigators with expertise in these areas to oversee these aspects of the study
and ensure scientific integration of analyses addressing several key questions. This group of investigators will
join the Physical Health Assessment Workgroup and review the quality of the data collected and make
recommendations regarding the collection of future waves of data collection. The Coordinating Center’s data
management group (DAIRC) will assist with capturing and monitoring the data. They will also work with the site
monitors and research coordinators/assistants at each of the 21 sites to ensure that they receive the training
needed to faithfully and accurately implement the designed protocols. Overall, the information gained as part of
the supplement will contribute to the open science ABCD data repository, enabling researchers to better
understand the connections between physiologic biomarkers, cognitive function, and brain development.

Public health relevance
PROJECT NARRATIVE The goal of this project is to augment the current data being collected in ABCD with information about the cardiometabolic and hematologic health of youth during adolescence. This supplemental information will allow us to gain a better understanding of the links between physiologic biomarkers, cognitive function, and brain development. Given the large sample size and diverse population participating in the ABCD Study, we will be able to develop a more nuanced understanding of these relationships as they pertain to different socio- demographic populations.